Developing prognostic models for life expectancy and geriatric outcomes

? DESCRIPTION (provided by applicant): 1 Prognosis is the risk of an outcome for a condition or disease, such as mortality of mobility impairment. A 2 prognostic index assembles the risk from multiple risk factors to predict outcome more accurately than a single 3 factor would predict on its own. Current prognostic indexes suffer either from being inaccurate, un- 4 interpretable, or both. Consequently, clinicians are unable to accurately determine prognosis in clinical 5 decision making for older adults, often leading to poor outcomes for patients. Many older adults are referred to 6 hospice in the last few hours or days before death, or never at all Other patients are exposed to the harms of 7 cancer screening without the possibility they will live long enough to benefit. Currently available prognostic 8 models estimate risk over a given time frame, such as risk of death over a 4 year period. Clinicians and 9 patients do not think of risk this way, however. They want to know how long do I have? This project will 10 address this question by making novel use of the exceptionally long follow up time in the nationally 11 representative National Institute of Aging-funded Health and Retirement Study. The objectives of this project 12 are to use the Health and Retirement Study (HRS) to develop and validate easy-to-use prognostic tools that 13 estimate life-expectancy and time to the onset of disability, inability to manage medications or finances, or 14 mobility impairment. Prognostic tools will be internally validated using the HRS and externally validated 15 using the English Longitudinal Study on Aging (ELSA). This approach leverages the fact that the ELSA was 16 based on the HRS. This project is expected to have a positive impact by informing, individualizing, and 17 improving clinical decision-making in older adults.

Public health relevance
PUBLIC HEALTH RELEVANCE: Older adults are routinely exposed to the harms of over-testing and over-treatment because clinicians cannot obtain essential information about how long a patient might have to live. The objective of this project is to create prognostic tools for estimating life expectancy and time to the onset of disability, difficulty managing finances or medications, and mobility impairment.